Project 4: Neoadjuvant Clinical Trial with Pembrolizumab for Locally Advanaced Squamous Cell Carcinoma (SCC)

This is a phase II single-arm neoadjuvant pembrolizumab trial in patients with PD-1 naïve resectable locally advanced SCC.

Public health relevance
N/A